Microscopy Imaging and Cellular Physiology Core

Project Summary/Abstract – Microscopy Imaging and Cellular Physiology Core
The Microscopy Imaging and Cellular Physiology (MICP) Core provides members of the Michigan Diabetes
Research Center access to state of the art microscopy imaging, in situ hybridization, and electrophysiologic
(including optogenetics) analysis, along with expert analysis and support. For over 20 years, the MICPC has
provided researchers use of confocal and wide-field microscopes to allow a wide array of cellular and tissue
imaging techniques including; imaging of fixed tissues and cells, quantification, co-localization, and live cell
imaging including FRET and FRAP experiments. We have now added in situ hybridization analysis with
fluorescent or radioisotope or chromogenic substrates for localization and/or quantification of mRNA. The core
also has also developed an electrophysiology laboratory that enables the analysis of electrical and ionic
changes in neurons, islets, or other relevant tissues, including optogentic activation of these tissues. Core
personnel provide extensive expertise in imaging, in situ hybridization and electrophysiology, enabling MDRC
investigators to rapidly develop novel experimental ideas and obtain high quality results with expert analysis.
Core personnel provide structured service, maintenance and expertise in imaging and cell physiology and
related experiments to support diabetes research at Michigan.